Small Animal Imaging Core

The Small Animal MultiModality Imaging Core (SAMMIC) has been set up specifically for imaging intact small animals, in particular mice and rats. There was an expressed need for in vivo assessment of genetically altered and tumor-bearing mice using noninvasive imaging techniques. The SAMMIC provides cancer investigators with a wide range of imaging technologies, including magnetic resonance imaging and spectroscopy, dual modality X-Ray and gamma imaging, micro positron emission tomography (MicroPET), bioluminescence and fluorescence imaging, image processing hardware and software, and a chemistry lab for the production of custom imaging agents. In addition, the SAMMIC staff, consisting of experts in their respective fields, assists investigators with the design and execution of experiments involving small animal imaging.